Infant Assessment of Early Communication Risk Factors: The ECBS

DESCRIPTION (provided by applicant): Effective early intervention depends on reliable identification of risk for communication impairments as soon as possible. Established infant risk factors for communication impairments include poor turntaking, gestures, receptive language, commenting, symbolic play, and speech. Although these risk factors can be detected by 12- 18 mos. and reliably predict later language and social development, attempts to detect similar risk factors in children 2-12 mos. have been unsuccessful because of extreme limitations in available assessments that typically include only 4-6 items for these infants'preintentional communication (i.e., reactive or active infant communication behaviors that are not directed toward listeners). There are no available normed assessments that provide comprehensive and dynamic data on infant preintentional communication and reflect evidence- based predictors that discriminate infants at risk for communication impairments before 12 months. When practitioners cannot detect infant behaviors known to be associated with communication risk, they cannot target early intervention to children with the greatest needs and potential for improvement. If we can identify communication risk early enough, we can intervene in the skills that predict later communication impairments and potentially mitigate effects of primary impairments in children and reduce the likelihood of secondary impairments that affect communication and other life skills. The plan for this project is to develop a predictive, comprehensive, modality-independent assessment to detect communication risk in preintentional infants 2-12 months (the Early Communication Behavior Scales, or ECBS). Pilot research by the Principal Investigator showed that a short behavior probe could reliably elicit preintentional communication behaviors from infants age 2-12 months that represent 11 evidence-based predictors of communication risk. These 11 predictors correspond to behavior clusters for the leading dynamic communication assessment for toddlers, the Communication and Symbolic Behavior Scales (Wetherby and Prizant, 1993;CSBS). A clear prediction of communication risk could justify the early involvement of speech-language pathologists for infants as well as for older children who have complex communication needs. We will use pilot data from administering the ECBS to typically developing infants 2-12 months, and collect new data from expert panel advice, score retrospective video data from preintentional infants with known disabilities, and test new samples of 100 typically developing preintentional infants 2-12 months of age, to achieve these specific aims: Identify ECBS domains that discriminate preintentional infants at risk for communication disabilities from typically developing infants, using video databases. Develop ECBS items, clusters, and a composite that account for domains that discriminate by age and at-risk disability status in existing infant samples. Establish the reliability and validity of the scale, cluster, and composite scores for the ECBS in a new sample of typically developing infants using correlational analyses, including exploratory factor analysis and cluster analysis. PUBLIC HEALTH RELEVANCE: We have recognized the need for detecting communication problems as early as possible so that we can start essential early communication intervention, but we do not presently have assessments that provide us enough information about how communication looks different in infants under 12 months at risk for communication disabilities. The Early Communication Behavior Scales (ECBS) would be the first comprehensive and normed assessment of communication for infants 2-12 months. With this tool, we could enhance our ability to provide clinical assessment and intervention to hone in on key communication skills during this period that make the greatest public health impact for infants with suspected communication risk factors. We can also use the ECBS to develop better intervention strategies for older children and adults who continue to need support with these early communication skills for longer than 12 months, and to predict effective changes in these early communication skills that vitally enhance quality of life and interaction for persons with significant communication challenges.

Public health relevance
We have recognized the need for detecting communication problems as early as possible so that we can start essential early communication intervention, but we do not presently have assessments that provide us enough information about how communication looks different in infants under 12 months at risk for communication disabilities. The Early Communication Behavior Scales (ECBS) would be the first comprehensive and normed assessment of communication for infants 2-12 months. With this tool, we could enhance our ability to provide clinical assessment and intervention to hone in on key communication skills during this period that make the greatest public health impact for infants with suspected communication risk factors. We can also use the ECBS to develop better intervention strategies for older children and adults who continue to need support with these early communication skills for longer than 12 months, and to predict effective changes in these early communication skills that vitally enhance quality of life and interaction for persons with significant communication challenges.